Mast cells in skin innate immune defense

ABSTRACT
We have demonstrated that mast cells entering the skin change phenotype triggered by contact with dermal
fibroblasts (DF). In the skin, Mast Cells (MCs) down regulate their TLR2 and increase the expression of genes
that downregulate the NFB, a known inflammatory pathway. This contributes to maintaining skin homeostasis
and makes mast cell tolerant to commensal bacteria. We found that DKK2, a specific protein secreted by DFs,
modulates the huMC NF–B pathway, by increasing gene expression of TNFAIP3 (A20) and NFKBIA in
huMCs. This modulation results in a decreased inflammatory response to commensal bacteria. In this
proposal, we will clarify the mechanisms of DF - MC signaling, which induces a MC skin tolerant phenotype.
This is an important mechanism for skin inflammation and atopic dermatitis (AD) in particular. We will present
preliminary data that show that in AD, DFs fail to maintain human MC (huMC) tolerance to commensal bacteria
which allows huMC to release proinflammatory cytokines. The idea that inflammatory diseases develop
because MC tolerance is broken represents a shift in science paradigm. This work will identify the mechanisms
underlying the roles of huMCs in building and breaking tolerance to the skin’s rich environment.
We propose the followings:
1. To determine whether TNFAIP3 (A20) and NFKBIA in human MCs are required for preventing
proinflammatory interleukin responses (tolerance) to commensal supernatant. In Aim 1 of this
proposal, we will use a variety of structural, biophysical, biochemical, and functional assays to
determine how dermal MCs collaborate with DFs. More specifically, we will analyze the MC expression
of the NF–B related genes, TNFAIP3 (A20) and NFKBIA, as well as receptors related to the innate
immune system in dermal huMCs.
2. To confirm that MC tolerance can be induced by DKK2 from DFs
In Aim 2, we will determine whether DF DKK2 is required for inducing huMC tolerance to commensal
supernatant and whether different DF sub-populations vary in their ability to induce tolerance in huMCs.
3. To confirm that DF-induced MC tolerance to commensal bacteria is critical for suppressing
human skin inflammation.
In Aim 3 of this proposal we will look at the consequences of the failure of huMCs to maintain tolerance
and their role in skin inflammation, specifically in Atopic Dermatitis skin.

Public health relevance
NARRATIVE Our preliminary data suggests, and current literature supports, that when mast cells (MCs) leave the blood and interact with dermal fibroblasts (DFs), they assume a bacterial tolerant phenotype to prevent unnecessary inflammation during the encounter with the beneficial commensal microbiome. This proposal will analyze the mechanisms that induce the MC tolerant phenotype in human skin, and how breaking this tolerance can induce inflammation and maintain diseases like atopic dermatitis (AD). The final goal of this proposal is to break the code of these interactions to allow design of new treatments for severe skin inflammation and AD specifically.